IgG and Adipose Pathological Remodeling

PROJECT SUMMARY
Obesity is responsible for numerous, highly prevalent comorbidities such as insulin resistance, type 2 diabetes,
cardiovascular diseases (CVDs), dyslipidemia, liver diseases, and cancers - all of which are indispensably
related to adipose tissue pathologies. Adipose tissue is vital for metabolic health and undergoes pronounced
pathological changes in obesity, including chronic inflammation, decreased adipogenesis, fibrosis, and impaired
metabolic function. Here the PI proposes to test an unconventional mechanism to integrate adipose tissue
pathological changes in obesity. He demonstrates a stark accumulation of immunoglobulin G (IgG) particularly
in white adipose tissues (WAT) in both aging- and diet-induced obese (DIO) mice, whereas caloric restriction (1),
the most effective intervention against metabolic dysfunctions, specifically reduces adipose IgG. IgG is the major
class of antibodies and is traditionally viewed as a circulating protein for immune defense. Administering
exogenous IgG in lean mice mimics obesity with an enriched distribution to WAT, impairs insulin sensitivity, and
induces adipose tissue inflammation. Depleting IgG in the whole body by knocking out (KO) the sole IgG
recycling protein FcRn in myeloid cells (FcRnflox/flox:LysM-Cre, FcRn-mKO) prevents high fat diet-induced weight
gain, adipose tissue inflammation and fibrosis, and metabolic dysfunctions. Furthermore, from a therapeutic
perspective, targeting FcRn by antisense oligonucleotides (ASO) inhibits IgG accumulation, improves
adipogenesis and brown remodeling, and restores metabolic functions in DIO mice. IgG treatment directly
induces inflammatory and fibrotic genes in adipocyte precursors and represses PPARg, the ultimate adipogenic
factor, resulting in impaired adipogenesis. Therefore, he hypothesizes that IgG is a critical factor that drives the
pathological remodeling of WAT and metabolic dysfunctions in obesity, and FcRn-dependent recycling is
required for its abnormal accumulation in WAT. By combining mouse genetic, biochemical, cellular, and
molecular approaches, he will critically test this hypothesis by the following specific aims. In Aim 1, he will first
understand how IgG is preferentially accumulated in WAT in obesity. Within WAT, FcRn is predominantly
expressed in adipose stromal cells (ASCs, Pdgfra+) and adipocytes. Therefore, he has conditionally knocked
out FcRn in ASCs (FcRnflox/flox:Pdgfra-Cre, FcRn-pKO) and adipocytes (FcRnflox/flox:Adipoq-Cre, FcRn-aKO). He
will dissect their respective contributions to adipose IgG accumulation and pathological remodeling. He will
further determine their effects on metabolic dysfunctions and whole-body IgG homeostasis in obesity. In Aim 2,
he will elucidate a molecular mechanism by which IgG impairs adipose functions through a Toll-like receptor 4
(TLR4)/PPARg axis. In summary, the proposed work will identify IgG as a pathogenic factor in the maladaptation
of WAT in obesity, thereby providing a mechanism that integrates the hallmarks of obese WAT. Uncovering the
requirement of FcRn in adipose IgG accumulation will incite a novel therapeutic strategy through targeting IgG
recycling to restore metabolic health in obesity.

Public health relevance
PROJECT NARRATIVE This project addresses a significant unmet medical need for curbing metabolic dysfunctions in obesity by investigating a novel mechanism underlying adipose tissue pathological remodeling. The proposed studies will establish the role of Immunoglobulin G (IgG) in adipose tissue dysfunction and further elucidate the regulatory and functioning mechanisms. This project will provide a novel therapeutic strategy by targeting IgG recycling to treat obesity and comorbidities.